Pathogenesis of Glaucomatous Optic Nerve Damage

Project Summary Abstract
While glaucoma is presently treated by lowering intraocular pressure (IOP), additional prevention of visual
impairment may come from altering the detrimental tissue responses to IOP. Initial reports from our team, now confirmed
by others, show that treatments affecting the cellular and connective tissues of the optic nerve head (ONH) are
neuroprotective. The earliest effects on retinal ganglion cell axons at the ONH in glaucoma are mediated by astrocytes and
microglia that respond to IOP-generated mechanical stress. Using mouse models and human glaucoma eyes, we have
identified key junctional complexes at the interface between astrocytes and sclera at the ONH that are altered by IOP
increase. Astrocytes at this location—the unmyelinated optic nerve (UON)—are relatively unique in structure to withstand
scleral hoop stress and the translaminar pressure gradient. We are engaged in detailed study of the components of these
junctional complexes and how they sense and translate stress into both beneficial and detrimental responses in glaucoma.
The elements of this junctional pathway are known to involve Rho-kinase (ROCK) and its study and manipulation are key
elements in the proposal. Astrocyte responses are now classified as protective or toxic in brain disease, and initial studies
suggest these occur in glaucoma, in part mediated by interaction with microglia. A specific inhibitor of microglial
activation of toxic astrocyte development (NLY01) will be studied for its mechanism of action and potential as therapy.
We have developed and will utilize quantitative, rigorous assays for the effects on astrocytes of alteration in their structure
and function, including ROCK inhibitors and the effects of transforming growth factor β pathway alterations. To facilitate
the development of translational agents in later full glaucoma models, we developed a quantitative assay for axonal
transport obstruction after 3 day IOP elevation. In a second major aim, astrocyte gene expression changes in the key UON
region with experimental glaucoma will be fully studied in primary astrocytes, whole eye explants, and living mouse eyes.
Both whole regional tissue digests and single cell RNAseq methodology is being employed to identify both how and in
which cells the changes occur. The protein expression changes attendant to these alterations will be related to
mechanosensation and mechanotranslation of astrocyte behavior and compared to quantitative structural changes at the
microscopic level. Specific activators and inhibitors of the identified pathways will be used to point to potential treatment
approaches. Several transgenic mouse models will be employed: 1) a strain with deficient laminin which is a key
component of the connection of astrocytes to sclera; 2) an angiopoetin1 knockout that produces a new glaucoma model of
higher IOP; and 3) a strain we have exploited to observe strain changes in the ONH in explants that has uniformly
fluorescent astrocytes. In the latter, we present specific alterations in astrocyte—sclera interaction that would provide
protection from or intensification of IOP-produced stress. To rule out that potential beneficial treatments are uniquely
useful only in one mouse model, we will use bead-injection and the angiopoetin mouse models, and laser-induced
glaucoma in the rat, each of which we have shown are amenable to therapeutic measures of ganglion cell soma and axon
preservation that are confirmed by both structural integrity and functional preservation.

Public health relevance
Project Narrative The research will study how supporting cells called astrocytes and microglia are important to the loss of vision caused by the eye disease, glaucoma. The pressure in the eye affects these cells, leading to both good and toxic effects on the important nerve cells whose death is the cause of glaucoma blindness. Treatments that come from this work are envisioned that would preserve vision in a process called neuroprotection.